Examining Perceived Familial and Self-Endorsement of Marianismo Cultural Script Discrepancies as Mental Health Risk Factors in Latina Americans

PROJECT SUMMARY/ABSTRACT
The prevalence of depression, anxiety, and stress symptoms among adult Latina-American individuals has
been on the rise despite strong familial-oriented belief systems 1–6. However, the exact role of marianismo as a
determinant and predictor has been argued as a simultaneous protective and risk factor. Conflict between
familial expectations and personal desires is thought to explain this health disparity 2-4. Basic psychological
needs theory (BPNT) links the undermining of personal autonomy with detrimental emotional affect, and is
hypothesized to have a unique, explanatory role in Latina familial-adult child relationships that result in
depression and anxiety. Familial support of marianismo – female-specified cultural scripts that prioritize familial
cohesion and spirituality – can directly suppress Latina-Americans' personal desires 7,8 and can explain why
Latinas are more susceptible to experiencing negative affect across their lifespan 9–13 . However, familial
support of marianismo, when not discrepant from self-endorsement can buffer the Latina against a multitude of
health disparities and explain protective qualities 14–19 . The broad aim is to test multi-domain relational and
individual mechanisms underlying depression, anxiety, and stress among Latina-American adults,
specifically examining personal versus familial marianismo belief discrepancy (or similarity) as a
potential source of tension enhancing risk of depressive and anxiety symptomology. Further, this
proposal employs (BPNT) to explain these differential mental health outcomes. BPNT autonomy (feeling
authentic) and relatedness (feeling belonging with the family) have demonstrated significant mental health
consequences for adult children when unsupported by familial relationships 20-22. However, no study has
investigated marianismo as differences in self versus familial beliefs, which satisfy or frustrate autonomy and
relatedness, in relation to Latina-American depression, anxiety, and stress. This proposal addresses these
gaps by (a) examining the links between marianismo self-endorsement and familial-endorsement as
determinants of risk to depression, anxiety, and stress symptomology; (b) illustrating and understanding need
frustrations (autonomy and relatedness) as explanatory mechanisms for negative mental affect; and (c)
conducting three mediational models representing different statistical strategies to capture discrepancy.
Further, in concordance with the National Institute of Minority Health and Health Disparities (NIMHD) goals to
identify mechanisms and protective factors of disparities, this study aims to elucidate how depression and
anxiety symptoms might be aggravated due to discrepancies between personal and familial beliefs in female
cultural scripts, thus integrating BPNT to explain these protective and risk factors unique to Latina-Americans.

Public health relevance
PROJECT NARRATIVE In line with NIMHD’s call for initiatives to resolve minority mental health disparities in Latina-American women, this proposal examines the explanatory role of family-endorsed gender scripts on mental affect such as depression, anxiety, and stress susceptibility. Utilizing social-psychological basic psychological needs perspectives, this proposed study examines cultural female gender script, marianismo, that has notably mixed protective or risk effects across behavioral and relational levels of analysis. To resolve this debate, this proposal is the first to identify discrepancies between familial expectations of women’s behavior and actual personal endorsement of traditional marianismo gender scripts as mapped onto relatedness and autonomy psychological needs within the self-determination theory framework. Further, this model examines the statistical validity of three separate operationalizations of marianismo self and familial-endorsed discrepancies that might buffer (or exacerbate) depression, anxiety, and stress symptoms in Latina-American women to better diagnose and tailor clinical interventions.